Unveil the Cereblon Target Atlas and Accelerate Molecular Glue Degrader Discovery

Project Summary/Abstract
Clinically credentialed immunomodulatory drugs bind to the substrate receptor cereblon (CRBN) within the
CRL4CRBN E3 ubiquitin ligase complex, creating a ‘neo-epitope’ on the CRBN surface that recruits non-
endogenous substrates (neosubstrates) with an 8-amino acid G-loop degron motif for subsequent ubiquitination
and proteasomal degradation. Such a drug modality is known as molecular glue degraders (MGDs), a subclass
of molecular glues (MGs) that are characterized by their ability to induce protein-protein interactions. A significant
gap remains in understanding the full scope of CRBN neosubstrates beyond the known G-loop-containing zinc
finger proteins in the human proteome, often leading to new CRBN interactors being discovered serendipitously.
Using bioinformatic analysis, we have identified 2,458 canonical G-loop targets as potential CRBN interactors
and aim to create a more comprehensive atlas of CRBN interactome. The overarching objectives of the proposed
work are: 1) to create a comprehensive atlas of CRBN interactome, encompassing canonical G-loop, mutant G-
loop, and even the hidden non-G-loop targets, and 2) to further validate these uncharted proteins as bona fide
CRBN interactors in the presence of novel MGDs. To achieve objective 1, we will leverage our expertise in
bioinformatic analysis, while realizing objective 2 will require the development of efficient target-based MGD
discovery methods, building on our knowledge of the CRBN interactome. We plan to employ not only a
degradation activity-first, protein-protein docking-guided rational design and screening approach, but also utilize
our DNA-encoded chemical library (DEL) platform to develop a ternary complex binding-first, unbiased DEL
screening approach. To showcase our strategy, we have prioritized several uncharted G-loop targets, aiming to
set compelling examples that will inspire future research into targeting the remaining predicted CRBN interactors
with the MGD modality. Upon completion, this proposed work will significantly expand our understanding of the
CRBN target landscape, and the molecular mechanisms and cellular pathways influenced by both existing and
future CRBN ligand-based MGDs. Given MGD’s unique proximity-inducing mechanism and chemical knockdown
pharmacology, our work is also poised to catalyze the development of numerous new CRBN-targeting MGD
chemical probes or drugs that address many previously ‘undruggable’ wild-type proteins and a significant number
of recalcitrant mutant proteins, thereby significantly advancing biomedical research and ultimately making a
difference in public health.

Public health relevance
Project Narrative This research aims to create a comprehensive target atlas for the CRL4CRBN E3 ubiquitin ligase, enabling the efficient discovery of molecular glue degraders (MGDs). These MGDs will enable the chemical knockdown of many previously 'undruggable' proteins, aiding in the investigation of key questions in medical sciences. Ultimately, it will enhance our pharmacological understanding of chemically modifying CRBN’s interactomes at both the cellular and molecular levels and will pave the way for novel CRBN ligand-based MGD drug design to improve public health.